Developmental origins and downstream consequences of abstract verbal reference

Project Summary/Abstract
Language is among our most powerful tools for learning and communication. It permits us to learn information that
does not, or cannot, manifest perceptually at the time of learning, such as historical facts, hypothetical scenarios, or scientific
constructs. This uniquely human power is enabled by abstract verbal reference–an appreciation that words are linked to mental
representations that can be established, retrieved and modified, even when their referents are perceptually unavailable. Despite
its utmost significance for human learning and communication, questions concerning the developmental origins (Aim 1) and
downstream consequences of attaining abstract verbal reference for broader language-mediated learning (Aim 2) remain.
To answer these questions, we will conduct one longitudinal and two cross-sectional eyetracking studies, focusing on
infants aged 12-22 months. To conduct cross-sectional studies (Experiments 1 and 2), we will develop a novel experimental
procedure that will evaluate infants’ ability to establish word-referent links from language input alone and will test infants
across a range of ages. The longitudinal study (Experiment 3) will leverage variation in young infants’ ability to resolve abstract
verbal reference and identify its consequences for the ability to learn facts from language input later in development.
Answering these questions will help us better understand the developmental origins of this fundamental human
learning capacity: extracting novel information from language alone, and creating and updating mental representations based on
it. The proposed research will have important theoretical implications for our understanding of early linguistic and
communicative development. For example, abstract verbal reference may not only extend the reach of infants’ word learning
(e.g., to include learning words from overhearing), but may also scaffold their ability to learn abstract concepts and their names.
These advantages may be related to infants’ vocabulary growth in the 2nd year of life (Goldfield & Reznick, 1990). Finally, this
research raises new theoretical questions. For example, a) What cues do infants rely on to resolve abstract verbal reference, and
b) How does infants’ reliance on these cues vary across languages and/or cultural contexts.
The proposed research also has strong methodological impact. The procedure in Experiment 1 offers a novel
methodological tool for investigating the development of abstract verbal reference in infancy. The semantic priming procedure
can be extended to investigate the breadth of infants’ representations of unseen referents. For example, does priming infants
with exemplars of superordinate categories lead to a more abstract representation of the target referent than priming with
exemplars of the same basic-level category? In addition, due to the use of continuous eyetracking measures over the course of
each trial, infants’ performance in this procedure will provide insight into the speed of infants’ processing of novel words
learned in the absence of their referents. The proposed research may also have clinical and pedagogical implications: infants’
ability to infer referents from language input alone is important in itself, but it may also predict their ability to engage in
language-mediated learning going forward. If so, the current results will inform interventions for children at risk of language
delays and low school readiness, because language-mediated learning is central to formal and much of informal instruction.
This work will also lay a foundation for examining potential effects of SES on infants’ success with abstract verbal reference.

Public health relevance
Project Narrative This proposal aims to advance our understanding of the fundamental human capacity to extract novel information encoded in language and to identify the downstream consequences of attaining abstract verbal reference for infants’ ability to learn novel facts from language alone. A clearer understanding of this relation will inform interventions designed to identify children at risk of language delays and low school readiness, because language-mediated learning is central to formal instruction. The proposed novel experimental procedure will offer a new methodological tool that will help advance basic research on the development of verbal reference and language-mediated communication.